Age-related changes in skeletal muscle and lower urinary tract symptoms in older adults

PROJECT SUMMARY/ABSTRACT
There is a fundamental knowledge gap and missed opportunities due to the current lack of understanding of
the relationship between age-related risk factors, such as loss of both global and pelvic skeletal muscle
function, and lower urinary tract symptoms (LUTS) among older women and men. LUTS are associated with
functional impairment and poor quality of life and are at increased risk of falls, fractures, and mortality. The
current narrow focus on urinary tract pathology has led to minimal understanding of what causes these
symptoms and correspondingly few effective interventions. A new aging-focused paradigm of LUTS
pathophysiology could lead to novel interventions to treat LUTs by defining modifiable LUTS risk factors, such
as age-related changes in muscle health, and mechanisms shared across syndromes of aging.
My goals are to build an epidemiologic backbone for understanding age-related LUTS risk factors by
leveraging high-quality existing data, defining novel and modifiable risk factors and mechanisms for age-
related LUTS, and to lead subsequent translational efforts to target these risk factors and mechanisms in older
adults. The objective of this application is to evaluate longitudinal associations between multiple measures of
skeletal muscle and LUTS. My hypothesis is that age-related changes in skeletal muscle – at the system
(strength and physical performance), organ (muscle mass/volume), and cellular (mitochondrial bioenergetics)
level – are associated with LUTS severity, independent of chronological age and confounding factors.
This hypothesis will be tested by efficiently using data from the prospective cohort “Study of Muscle Mobility
and Aging” (SOMMA) to pursue the following specific aims: Aim 1) Determine how baseline and longitudinal
changes in muscle function (strength, power) and physical performance (walking speed) are associated with
change in LUTS severity; Aim 2) Determine how baseline and longitudinal changes in muscle mass and
baseline measures of both total body and pelvic floor muscle volume and shape are associated with change in
LUTS severity; and Aim 3) Determine how baseline measures of skeletal muscle mitochondrial function are
associated with change in LUTS severity. This project is innovative because it leverages the rapidly evolving
field of geroscience to improve the inadequate existing urogenital-focused paradigm of LUTS pathophysiology.
The proposed research is significant because it will produce a paradigm of age-related LUTS pathophysiology
that will result in improved care for older adults with LUTS by 1) identifying biomarkers of age-related LUTS; 2)
improving the benefit:risk ratio for existing therapies by stratifying based on novel LUTS phenotypes; 3)
distinguishing the role of changes in global versus pelvic floor muscles in the development of LUTS; 4)
facilitating the development of new treatments that target age-related LUTS mechanisms; and ultimately 5)
preventing LUTS complications (e.g., frailty, impaired mobility, falls, and poor quality of life) that may be directly
caused by LUTS or indirectly caused by shared modifiable factors for which LUTS is an early marker.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because a majority of women and men will experience lower urinary tract symptoms in their lifetime, but existing treatments have limited efficacy and important risks. Understanding new age-related mechanisms of lower urinary tract symptoms will lead to more accurate diagnosis and novel individualized treatments that improve or maintain health-related quality of life and physical function in older adults. Thus, the proposed research is relevant to the NIA's strategic goal to understand the dynamics of the aging process and to improve the health, well-being, and independence of older adults.